Novel immunotherapy against MOG antibody disease

PROJECT SUMMARY/ABSTRACT
Myelin oligodendrocyte glycoprotein (MOG) antibody disease (MOGAD) is a rare disease characterized as a
neurological, inflammatory, demyelinating disorder of the central nervous system. The symptoms of MOGAD
include vision loss, symptoms associated with damage to the spinal cord, as well as seizures. While the current
standard of care against MOGAD includes steroids and immunosuppressants, they are associated with systemic
immunosuppression with complications and frequent debilitating relapses. Thus, there is an urgent need for new
targeted treatment options for MOGAD patients. As MOG is the sole target antigen in MOGAD patients, MOG is
an attractive target. Here, we propose to develop a novel nanoparticle platform for the treatment of MOGAD.
Toward this goal, we have developed synthetic high-density lipoprotein NanoDiscs for efficient delivery of antigen
peptides to lymph nodes. Our preliminary data shows that NanoDiscs induce robust antigen-specific immune
tolerance and disease modification in murine models of experimental autoimmune encephalomyelitis (EAE) and
another autoimmune disorder, type 1 diabetes (T1D). Based on our compelling proof-of-concept data, here we
propose to further develop NanoDiscs for the treatment of MOGAD.

Public health relevance
PROJECT NARRATIVE The objective of this project is to develop an effective treatment for myelin oligodendrocyte glycoprotein antibody disease (MOGAD), for which there is no cure. While the current standard of care against MOGAD includes steroids and immunosuppressants, they are associated with systemic immunosuppression with complications and frequent debilitating relapses. Broad B-cell modulating agents have been developed (i.e., rituximab) and showed efficacy in a subset of MOGAD patients; however, it does not confer long-term protection and has risks of deleterious cytokine responses, anaphylactic shock, and increased susceptibility to infections. Thus, there is an urgent need for new targeted treatment options for MOGAD patients. The proposed research will produce a novel vaccine-like strategy for MOGAD, open up avenues to treat other autoimmune diseases, and lead to new strategies to achieve disease control.